Bioengineering strategies for exogenic organ production

ABSTRACT
The overall goal for this revised Phase 1 grant proposal is to significantly enhance the efficiency of
generating human vasculature in a pig. This product will provide an unlimited number of organs (such as
hearts) for xenotransplantation and will be associated with decreased immunological barriers. Problem: The
only curative therapy for endstage diseases such as heart failure is solid organ transplantation. Millions of
patients (worldwide) could benefit from such therapy but are not eligible for transplantation due to limited donor
organ availability. Therefore, there is an urgent need to develop alternative organ sources for transplantation.
Our early stage prototype, using somatic cell nuclear transfer technology (SCNT; cloning) and blastocyst
complementation provides proof of concept for the feasibility of our platform and patented technology whereby
we have successfully engineered viable and normal intraspecies porcine chimeras and have further generated
human vasculature in early staged porcine embryos. While our publications and patents indicate the importance
and feasibility of this platform approach, the process of SCNT is inherently inefficient. Solution: Therefore, in
order to transform the field and maximally increase the efficiency of engineering vasculature in a gene edited
pig, we will compare our proven (and published) approach using SCNT with in vitro fertilization/zygote gene
editing/blastocyst complementation. In this Phase I grant application, we predict that zygote editing and
blastocyst complementation will provide a more efficient and economical platform for the production of human
vasculature and these human-porcine chimeras will serve as an unlimited source of organs (such as hearts) for
exogenic organ transplantation. As outlined in this Phase I proposal, we will pursue our specific aims, achieve
our five milestones and produce four products. The successful completion of the Phase I studies will provide a
platform to exponentially increase the production exogenic organs for research and therapies to fulfill an unmet
and urgent need. Live, fully functional interspecies chimeras that have either a completely nonhuman primate
(macaque) or humanized vasculature in a gene edited pig will be produced in the future Phase II proposal.

Public health relevance
Project Narrative This research projects seeks a dramatic improvement in the efficiency and production of exogenic organs that someday will impact patient care. The overall goal is to improve the speed, the production and the economic efficiency of this critical early phase of product development. Achievement of milestones and product development will provide a platform for the Phase II grant application.